Hepatic Mitochondrial Respiratory Activation, Depolarization and Recovery After Acute Ethanol

ABSTRACT
Liver failure is a major cause of death worldwide. Hepatic mitochondrial depolarization (mtDepo) is one of
the earliest responses to ethanol and likely is the first in a chain of events leading to subsequent liver disease.
Initially, mtDepo in response to ethanol facilitates more rapid two-step oxidation of ethanol and its toxic metabolite
acetaldehyde (AcAld) to acetate. I hypothesize that mtDepo underlies a swift increase in alcohol
metabolism (SIAM) after acute ethanol administration that is an adaptive response to eliminate ethanol
more rapidly. Chronically, the response becomes maladaptive leading to disordered mitophagy and hepatic
inflammation and fibrosis. Furthermore, I hypothesize that mtDepo after EtOH is brought about via mitochondrial
uncoupling due to proton leaks through either the adenosine nucleotide translocator (ANT1/2), the mitochondrial
F1FO-ATP synthase, uncoupling proteins (UCPs) or mitochondrial permeability transition (PT) pores. Since
mtDepo leads to elimination of mitochondria by mitophagy, I also hypothesize that recovery from mtDepo
after ethanol involves mitochondrial biogenesis. In two Specific Aims, I will: 1) Characterize hepatocyte
mitochondrial oxygen consumption rate (OCR) in relation to mitochondrial depolarization and
repolarization after acute ethanol. I will assess time-dependent changes in OCR and mitochondrial membrane
potential (ΔΨ) of hepatocytes freshly isolated from ethanol-treated and untreated mice using Seahorse
extracellular flux analysis, Hansatech oximetry, and confocal microscopy of fluorescent ΔΨ indicators. By
injecting in vivo prior to hepatocyte isolation MitoTracker dyes, fluorophores that label only polarized
mitochondria, I will identify hepatocytes having undergone mtDepo in vivo in relation to mtDepo and
repolarization in vitro. To address my mechanistic hypotheses, I will assess how specific inhibitors of ANT, ATP
synthase, UCPs, and PT pores reverse/prevent ethanol-induced mtDepo and increased OCR. 2) Assess the
role of mitochondrial biogenesis and mitophagy in recovery from mtDepo after acute ethanol. As mice
metabolically eliminate ethanol, hepatocytes recover from mtDepo. In Mitotimer mice, newly synthesized DsRed-
E5 fluoresces green but over time (12-24 h) shifts irreversibly to red fluorescence. If repolarization of preexisting
mitochondria occurs after ethanol, then Mitotimer fluorescence should be predominantly red in mitochondria
recovering from mtDepo. If repolarization results from mitochondrial biogenesis, then recovering mitochondria
will fluoresce green. I expect that repolarization of preexisting mitochondria and biogenesis of new mitochondria
will both contribute to recovery from mtDepo after acute ethanol. Together, Aims 1 and 2 will characterize key
mechanisms in the hepatic mitochondrial response to ethanol, as well as identify the basis for recovery. This
fundamental knowledge could lead to development of new therapeutics to treat and prevent alcoholic liver
disease.

Public health relevance
Project Narrative Alcoholic liver disease leads to cirrhosis and liver failure and is one of the leading causes of deaths worldwide. This project will characterize the hepatic mitochondrial response to ethanol, specifically ethanol-induced mitochondrial depolarization (mtDepo) with subsequent swift increase in alcohol metabolism (SIAM), as well as the recovery of hepatic mitochondria after ethanol by repolarization and biogenesis. Furthermore, the project will determine the possible roles of the adenosine nucleotide translocator, the mitochondrial ATP synthase, uncoupling proteins, and mitochondrial permeability transition pores in producing proton leaks to cause mtDepo after ethanol.